Project 2 - Provider-Patient/Caregiver Racial Concordance and Equity in Health Care Systems: Their Influence on Health and Healthcare Outcomes for Populations with ADRD

OTHER PROJECT INFORMATION – Project Summary/Abstract
Project 2 – Provider-Patient/Caregiver Racial Concordance and Equity in Health Care Systems: Their
Influence on Health and Healthcare Outcomes for Populations with ADRD
Although more than 16 percent of the US population identifies as Hispanic and 12 percent as Black, less than 6
percent of physicians identify as Hispanic and 5 percent as Black. The proposed project will harness several
decades of Medicare data from rural and urban regions to shed light on the role of patient/provider racial
concordance in driving health outcomes for patients with Alzheimer’s disease and related dementias (ADRD) as
well as others. Using novel data sources on physician race and ethnicity, together with quasi-experimental
variation in the “match” that occurs in Emergency Department (ED) settings as well as an instrumental variables
strategy, we will estimate causal impacts of this concordance on healthcare and health, including ED visits for
ambulatory care sensitive conditions, in-patient admissions, readmissions, healthy days in the community,
medication adherence, and mortality. In addition, we will examine factors that mediate those outcomes and how
the effects may change over time. ADRD patients comprise a large fraction of Medicare beneficiaries who present
in EDs and are highly reliant on primary care physicians because of shortages of specialists. Finally, we will
compare the impact of racial (non-)concordance in ambulatory care settings, where greater sorting may occur, to
emergency department settings, where there is quasi-random assignment of patients to providers. Project 2
anchors the Program Project’s focus on racial disparities in care, complementing the work of other projects that
also look at racial disparities in care for ADRD patients and others in other contexts.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative Provider/patient racial concordance and workforce diversity in medicine is an understudied topic, despite its importance for medical decision making and patient wellbeing. Concordance may impact trust and other social factors that may be particularly important for patients with ADRD because of diminished ability for self- advocacy. Prior evidence suggests that minoritized patients’ trust in medicine may be enhanced when they are paired with a race-concordant provider. This project will investigate the extent of racial concordance between providers and patients, drivers of concordance, and causal impacts of a concordant match on health care use and health.